Project 2: Targeting Glutamine Metabolism to Enhance EGFR Blockade in Wild-Type RAS CRC

PROJECT SUMMARY/ABSTRACT: P2. Targeting Glutamine Metabolism to Enhance EGFR Blockade in
WT RAS CRC
Colorectal cancer (CRC) is the second leading cause of cancer-related death in the US. A wealth of
proteogenomic information has provided a deep understanding of the molecular pathogenesis of CRC and has
led to improved classification systems of the disease. However, matching a CRC patient to the optimum
therapeutic regimen remains a major challenge. Epidermal growth factor receptor (EGFR) neutralizing
monoclonal antibodies (mAbs; e.g., panitumumab) are approved for patients with advanced wild-type (WT)
RAS CRC. However, in late-line therapy, only 12–17% of patients exhibit durable responses to EGFR mAb
monotherapy and addition of EGFR mAbs to standard chemotherapy has limited clinical benefit. Clearly,
therapeutic strategies that enhance efficacy of EGFR mAb and/or overcome resistance are needed, along with
novel ways to prioritize patients for such therapy. The metabolic requirements of proliferating cells link signal
transduction with nutrient accumulation, resulting in a direct link between proliferation and metabolism.
Glutamine (Gln) is a key anaplerotic substrate used by cancer cells, providing energy, carbon, and nitrogen to
meet the demands of rapid and sustained growth. Gln replenishes the supply of tricarboxylic acid (TCA) cycle
intermediates used to fuel biosynthesis, and also plays a critical role in depleting cytotoxic reactive oxygen
species (ROS). In many cancers, EGFR and Gln cooperate to provide both `signals' and `fuel', which are
required for mitogen activated protein kinase (MAPK)-dependent growth and proliferation. The Scientific
Premise of this project is that Gln provides a `fuel' source to support EGFR-mediated proliferation; blocking
Gln metabolism will deplete a critical metabolic `fuel' required for cell growth and proliferation. The Overall
Hypothesis is that inhibition of Gln metabolism will enhance EGFR mAb therapy for a select group of patients
with CRC who have failed prior EGFR mAb-containing regimens. We propose to evaluate non-invasive PET
imaging as a biomarker of Gln avidity, from which we will develop a Gln PET-derived gene signature. A gene
signature of Gln avidity will allow this information to be utilized in lieu of complex PET imaging. Our project has
three Specific Aims. Aim 1. Conduct a phase II clinical trial evaluating the efficacy of combined CB-839 and
panitumumab in patients with WT RAS CRC who progressed on prior anti-EGFR mAb therapy. Aim 2.
Evaluate quantitative Gln PET in EGFR mAb-naive and EGFR mAb-refractory patients to predict response to
therapy. Aim 3. Develop a PET imaging-derived gene signature of Gln avidity to predict responsiveness to
inhibitors of Gln metabolism. Spanning laboratory studies and clinical trials, deliverables of this project include
a new therapeutic combination to improve response and overcome resistance to anti-EGFR mAb therapy in
WT RAS CRC, as well as a new way to identify patients likely to benefit from inhibitors of Gln metabolism.

Public health relevance
PROJECT NARRATIVE: P2. Targeting Glutamine Metabolism to Enhance EGFR Blockade in WT RAS CRC Epidermal growth factor receptor (EGFR) neutralizing monoclonal antibodies are approved for treatment of advanced wild-type (WT) RAS colorectal cancer (CRC) and commonly used as targeted therapies for late-stage metastatic CRC. However, durable responses to anti-EGFR monotherapy occur in only 12–17% of patients and resistance to monoclonal antibody (mAb) therapy commonly occurs. Prioritizing glutamine metabolism as an actionable vulnerability in WT RAS CRC, we propose a two-pronged translational approach to optimize EGFR therapy that includes a novel way to prioritize patients for EGFR-targeted therapy, novel positron emission tomography (PET) imaging as a predictive marker, and a novel therapeutic combination.